Whole genome sequences in ethnically diverse individuals with functional assays and genome editing to characterize the biology of plasma lipids

PROJECT SUMMARY / ABSTRACT
Coronary heart disease is the leading cause of death worldwide. Characterizing the inherited basis of plasma
lipids, the strongest risk factor for coronary heart disease, has led to key biological and clinical insights. Large-
scale deep-coverage whole genome sequencing is now feasible and offers the opportunity to characterize full
genomic variation within a given individual. For any one individual, however, the interpretation of genomic
variation is limited by 1) ethnic-specific impacts, and 2) prediction of functional impact, particularly for rare,
non-coding variants. The goal of this R01 proposal is to fully characterize the inherited basis of plasma lipids
through a novel `trans-omics' approach – complementing whole genome sequencing with novel statistical
genetics and functional genomics. In Aim 1, we will discover novel genomic variation from ~100,000 ethnically-
diverse individuals and associate with plasma lipids. We will complementarily use data-driven bioinformatic
approaches to identify novel genetic regions. In Aim 2, we will improve the genomic diagnosis of familial
hypercholesterolemia, characterized by severe hypercholesterolemia and marked increased risk for premature
coronary heart disease. We will incorporate ethnicity, functional annotations, and pleiotropy to develop a novel
polygenic model for familial hypercholesterolemia. We will jointly model the monogenic and polygenic
components for risk of familial hypercholesterolemia. In Aim 3, we identify functional rare non-coding
hypercholesterolemia variants with cell-based massively parallel reporter assays and CRISPR-based methods.
We will further use these insights to improve power for discovering novel genes from whole genome sequence
analysis. This work leverages data being generated within the NHLBI Trans-Omics for Precision Medicine
(TOPMed) program. We have extensive expertise in whole genome sequence analysis, statistical genetics,
functional genomics, and cardiovascular medicine. This proposal includes methodological, computational, and
experimental innovations, and builds on established collaborative relationships between investigators with
complementary strengths. Completion of our aims will yield novel insights to inform prevention, diagnosis, and
treatments for coronary heart disease. Furthermore, we will demonstrate broad framework for trans-omics
analysis to identify causally relevant genomic variants for both research and clinical genetic applications.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Characterizing the genetic basis of plasma lipids has spurred many key paradigms for preventing cardiovascular disease – biological insights, risk prediction, and medicines. Whole genome sequencing now offers the prospect of identifying all the potential genetic factors influencing lipids. However, for an individual genome, interpretation is limited by knowledge gaps regarding 1) ethnic differences, and 2) understanding the genome outside (98.5%) of protein-coding regions (1.5%), so we seek to complement whole genome sequence analysis with genomic variation characterization in humans and cells using new technological, statistical, and bioinformatic approaches. The goal is to improve risk prediction and tailored preventive care as well as find new genes, which can be therapeutically targeted to reduce the prevalence of cardiovascular disease.